Neuroethics and human-centered design in neurotechnology

PROJECT SUMMARY/ABSTRACT
Empirical neuroethics studies of patient/user perspectives have demonstrated profound effects that
novel neurotechnological therapies, such as implanted devices, can have on people’s understandings
of themselves and their illnesses. However, to date the incorporation of such perspectives in the design
of neurotechnologies is not a standard practice, and this gap presents risk for ethical harms and may
negatively impact the usability and feasibility of interventions based on BRAIN Initiative-supported
research. The long-term goal of this proposal is to facilitate the BRAIN Initiative’s success in discovering
effective and ethically sound therapies for disorders of the nervous system. The central hypothesis is
that human-centered design, an interdisciplinary approach that prioritizes user perspectives and has
been successfully applied to implementation problems in fields such as digital technology and health
systems design, can be applied to related problems in neurotechnology. The work will be conducted by
pursuing three specific aims: 1) Examine adverse user experiences with non-human-centered design,
highlighting pitfalls and needs for improvement; 2) Assess prevailing attitudes regarding human-
centered design and barriers to adoption among neurotechnology developers; and 3) Convene
neurotechnologists to identify needs and to develop strategies for integrating user perspectives in
neurotechnology. Under the first aim, in-depth qualitative interviews will be conducted with blind people
implanted with the Argus II retinal implant, a commercially non-viable technology no longer supported
by its manufacturer, which may illustrate how failures to incorporate user perspectives in design can
lead to ethical harm and to technology abandonment. For the second aim, professionals engaged in
neurotechnology (including neuroscientists, engineers, businesspeople, and officials/regulators) will be
interviewed about incorporating user perspectives generally and about human-centered design
specifically. These interviews will offer insight into the lack of adoption of human-centered design in
neurotechnology to date. In the third aim, two convenings of neurotechnologists will be organized to co-
create plans for making the incorporation of user perspectives a standard practice in neurotechnology.
The approach is innovative, shifting research paradigms in neuroethics and neurotechnology through
new conceptual and methodological linkages with human-centered design. The proposed research is
significant, because the ethical and effective provision of novel treatments depends on incorporating
the priorities of patients and prospective users more directly in their design. Ultimately, we envision a
mutually reinforcing relationship between neuroethics and human-centered design, two interdisciplinary
fields that can bring needed new outlooks and methods to the practice of neuroscience.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH SIGNIFICANCE The proposed research is relevant to public health because it proposes applying human-centered design, an established approach that has been successfully applied to implementation problems in other domains of technology, to the challenge of incorporating patient/user perspectives in the design of novel neurotechnologies. Human-centered design in neurotechnology holds potential to address key neuroethical problems and also to enhance the usability and feasibility of new treatments based on BRAIN Initiative-supported research. Thus, the proposed research is relevant to the NIH’s mission of applying knowledge to enhance health and to reduce illness and disability.